ACORN: Administrative and Planning Core

The Alcohol Center Of Research Nebraska (ACORN) Administration and Planning Core (APC), described
here, provides planning, oversight, leadership, and management, as well as centralized services to all Cores,
projects, programs, and investigators in the Center. APC engages the External Advisory Committee in the
strategic planning of the Center's research and outreach. APC conducts ACORN’s governance by leading the
Center's public relations, communication with stakeholders, scientific meetings, and engagement of the alcohol
research community. APC provides the administrative structure for day-to-day management, planning,
budgeting, IRB compliance, and other essential functions. Evaluation of the individual Cores, Research
Projects, Pilot Projects, and the Center as a whole will be an essential function of the APC. APC will also
provide administrative support for these programs. APC coordinates the administrative functions and contracts
with any outside institutions, partners, and consultants participating in Center projects. APC manages the
Center's website, social media presence, media releases, information requests from the media and the
public, and representation of the Center in meetings and public events. The Specific Aims of the APC are to:
1) Provide the Center Leadership with a mechanism for planning, coordinating, and evaluating research;
2) Engage the External Advisory Committee in the planning and governance of the Center; 3) Oversee fiscal
and resource management, maintain records, and compile Center reports; 4) Facilitate seminars, meetings,
workshops, advisory committee meetings and conferences; and 5) Provide centralized services to investigators
regarding information technology, research design, biostatistics, recruiting subjects, surveillance, outreach, and
evaluation.